IGNITE KUH NRSA Training Core

Contact PD/PI: Okusa, Mark D. NRSA-Training-001 (883)
NRSA TRAINING CORE ABSTRACT
The Integrated Virginia Research Training Centers in Kidney, Urology and Hematology (IGNITE
KUH) training program is being proposed to address an unmet need and major gap in prioritized
research training through development and integration of a statewide research program in the
Commonwealth of Virginia. The IGNITE KUH NRSA Training Core is an innovative and distinctive
multi-institutional, multi-departmental program comprising a team of 65 outstanding faculty from
the University of Virginia (UVA), Virginia Commonwealth University (VCU), and Virginia
Polytechnic Institute and State University (VT) with primary research programs anchored in the
basic research and clinical science of benign KUH diseases in six thematic areas: Systems
Biology and Functional Genomics, Immunity and Inflammation, Biomedical Engineering,
Nanotherapeutics and Drug Discovery, Clinical and Data Sciences, and Predictive Analytics. The
NRSA Training Core leverages existing strengths in kidney and hematological disease research,
uniting them with urological disease research in a cohesive, integrated and coordinated research
training program. The NRSA Training Core will be enhanced through participation and integration
of the Translational Health Research Institute of Virginia (iTHRIV), a component of the Clinical
and Translational Science Award (CTSA) partnership between UVA and VT, and the Wright
Center for Clinical and Translational Research (CCTR) at VCU. Three major goals of the IGNITE
KUH NRSA Training Core include: 1) increase training of PhD students, residents (urology) and
postdoctoral fellows in basic and translational aspects of KUH in health and disease using a
unified approach; 2) establish an integrated Virginia-wide research training program focused on
KUH-diseases; and 3) attract outstanding students and postdoctoral fellows with long-term career
interests in basic or clinical research into the IGNITE KUH Training Program. IGNITE KUH will
prioritize strategies to attract students from underrepresented populations at several partner
institutions, including three historically black universities in Virginia – Virginia State University
(VSU), Hampton University (HU), and Virginia Union Universities (VUU) – thereby further
enhancing development and training of both PhD researchers and physician scientists. The
IGNITE KUH NRSA Training Core will address human health issues through increased education
and training of the next generation of researchers and physician scientists in basic research or
clinical science who can guide and lead future research programs aiming to lessen human
disease and suffering in KUH-specific fields.
Project Summary/Abstract Page 322
Contact PD/PI: Okusa, Mark D. NRSA-Training-001 (883)
References
1. Jager KJ, Kovesdy C, Langham R, Rosenberg M, Jha V, Zoccali C. A single number for advocacy and
communication-worldwide more than 850 million individuals have kidney diseases. Kidney Int
2019;96:1048-50.
2. Stapleton FB, Andreoli S, Ettenger R, Kamil E, Sedman A, Chesney R. Future workforce needs for pediatric
nephrology: an analysis of the nephrology workforce and training requirements by the Workforce
Committee of the American Society of Pediatric Nephrology. J Am Soc Nephrol 1997;8:S5-8.
3. Rosner MH, Berns JS. Transforming Nephrology. Clin J Am Soc Nephrol 2018;13:331-4.
4. de Boer IH. Nephrology at a Crossroads. Clin J Am Soc Nephrol 2018;13:324.
5. Lane CA, Brown MA. Nephrology: a specialty in need of resuscitation? Kidney Int 2009;76:594-6.
6. Tonelli M, Wiebe N, Manns BJ, et al. Comparison of the Complexity of Patients Seen by Different Medical
Subspecialists in a Universal Health Care System. JAMA Netw Open 2018;1:e184852.
7. McKibben MJ, Kirby EW, Langston J, et al. Projecting the Urology Workforce Over the Next 20 Years.
Urology 2016;98:21-6.
8. Washington SL, 3rd, Baradaran N, Gaither TW, et al. Racial distribution of urology workforce in United
States in comparison to general population. Transl Androl Urol 2018;7:526-34.
9. Woldu SL, Raj GV. Surgery: The surgeon-scientist - a dying breed? Nat Rev Urol 2016;13:698-9.
10. Keswani SG, Moles CM, Morowitz M, et al. The Future of Basic Science in Academic Surgery: Identifying
Barriers to Success for Surgeon-scientists. Ann Surg 2017;265:1053-9.
11. Hougen HY, Lobo JM, Corey T, et al. Optimizing and validating the technical infrastructure of a novel tele-
cystoscopy system. J Telemed Telecare 2016;22:397-404.
12. Sharma D, Wallace N, Levinsohn EA, et al. Trends and factors affecting the US adult hematology
workforce: a mixed methods study. Blood Adv 2019;3:3550-61.
13. Hoots WK, Abkowitz JL, Coller BS, DiMichele DM. Planning for the future workforce in hematology
research. Blood 2015;125:2745-52.
14. Soffer E, Hoots WK. Challenges facing the benign hematology physician-scientist workforce: identifying
issues of recruitment and retention. Blood Adv 2018;2:308.
15. Perry HM, Huang L, Ye H, et al. Endothelial Sphingosine 1Phosphate Receptor1 Mediates Protection and
Recovery from Acute Kidney Injury. J Am Soc Nephrol 2016;27:3383-93.
16. Bajwa A, Huang L, Kurmaeva E, et al. Sphingosine Kinase 2 Deficiency Attenuates Kidney Fibrosis via
IFN-gamma. J Am Soc Nephrol 2016;28:1145-61.
17. Bajwa A, Rosin DL, Chroscicki P, et al. Sphingosine 1-Phosphate Receptor-1 Enhances Mitochondrial
Function and Reduces Cisplatin-Induced Tubule Injury. J Am Soc Nephrol 2014.
18. Bajwa A, Huang L, Ye H, et al. Dendritic cell sphingosine 1-phosphate receptor-3 regulates Th1-Th2
polarity in kidney ischemia-reperfusion injury. J Immunol 2012;189:2584-96.
19. Bajwa A, Jo SK, Ye H, et al. Activation of sphingosine-1-phosphate 1 receptor in the proximal tubule
protects against ischemia-reperfusion injury. J Am Soc Nephrol 2010;21:955-65.
20. Jo SK, Bajwa A, Ye H, et al. Divergent roles of sphingosine kinases in kidney ischemia-reperfusion injury.
Kidney Int 2009;75:167-75.
21. Jo SK, Bajwa A, Awad AS, Lynch KR, Okusa MD. Sphingosine-1-phosphate receptors: biology and
therapeutic potential in kidney disease. Kidney Int 2008;73:1220-30.
22. Kao LP, Morad SAF, Davis TS, et al. Chemotherapy selection pressure alters sphingolipid composition and
mitochondrial bioenergetics in resistant HL-60 cells. J Lipid Res 2019;60:1590-602.
23. Gigliotti JC, Huang L, Ye H, et al. Ultrasound prevents renal ischemia-reperfusion injury by stimulating the
splenic cholinergic anti-inflammatory pathway. J Am Soc Nephrol 2013;24:1451-60.
24. Tanaka S, Inoue T, Hossack JA, Okusa MD. Nonpharmacological, Biomechanical Approaches to Control
Inflammation in Acute Kidney Injury. Nephron 2017;137:277-81.
25. Gigliotti JC, Huang L, Bajwa A, et al. Ultrasound Modulates the Splenic Neuroimmune Axis in Attenuating
AKI. J Am Soc Nephrol 2015;26:2407-81.
26. Chappell JC, Song J, Burke CW, Klibanov AL, Price RJ. Targeted delivery of nanoparticles bearing
fibroblast growth factor-2 by ultrasonic microbubble destruction for therapeutic arteriogenesis. Small
2008;4:1769-77.
27. Anderson AH, Xie D, Wang X, et al. Novel Risk Factors for Progression of Diabetic and Nondiabetic CKD:
Findings From the Chronic Renal Insufficiency Cohort (CRIC) Study. Am J Kidney Dis 2020.
References Cited Page 323